A CRISPR-based toolkit for investigating hair cell transcription factors in inner ear organoids

PROJECT SUMMARY/ABSTRACT
Hair cells (HCs) are the specialized sensory cells of the inner ear that play a crucial role in transmitting
environmental information, such as sound and motion, to the brain. In adult mammals, HCs cannot regenerate
naturally. Therefore, a large effort has been made to understand the normal development of auditory and
vestibular HCs, so that effective regenerative therapies can be established. Technological advancements in
studying transcriptional control have provided valuable insights into the roles of different transcription factors
(TFs) such as ATOH1, POU4F3, GFI1, INSM1, TBX2, and IKZF2 in the development of HCs. However, the
application of certain tools, such as CRISPR-mediated gene activation and inhibition, for studying HC
development has been limited by the complicated use of animal models. Recently, a highly scalable protocol
was developed to guide mouse embryonic stem cells (mESCs) towards inner ear sensory cells in vitro. Over a
span of 2-3 weeks, these inner ear organoids produce sensory epithelia-like structures complete with
mechanosensitive HCs and underlying supporting cells. The development of this inner ear organoid model
facilitates the progress of cell-based assays for studying HC-specific development and testing potential
treatments for sensory cell loss. In this proposal, I aim to utilize the inner ear organoid model to investigate the
transcriptional control of HC development in vitro. To achieve this, I plan to:
I. Define the TFs involved in in vitro inner ear organoid HC development compared to in vivo HC
development.
II. Generate a versatile toolkit of mESC lines designed for inducible and reversible CRISPR-mediated gene
activation and inhibition.
III. Utilize this toolkit to systematically investigate the roles of candidate TFs in organoid HCs through
CRISPR-mediated knockdown and activation, followed by multi-omic analyses.
Successful completion of this project will not only uncover additional TFs essential for HC development but will
also provide a valuable resource for fellow inner ear researchers seeking to manipulate the expression of genes
of interest within inner ear organoid cell types.

Public health relevance
PROJECT NARRATIVE Recent advancements in studying transcriptional control have shed light on the roles of specific transcription factors (TFs) such as ATOH1, POU4F3, GFI1, INSM1, TBX2, and IKZF2 in inner ear hair cell (HC) development. To further this research, I propose using the newly developed inner ear organoid model to study and manipulate HC development in vitro. This project aims to identify key TFs involved in organoid HC development, create a versatile CRISPR-based toolkit for gene manipulation, and systematically investigate TF roles through CRISPR- mediated techniques and multi-omic analyses, offering key insights into HC development and aiding future regenerative research in the field.